National Community, Family, and Peer Support Core

This Core facilitates research on and the development and evaluation of interventions leveraging community, peer, and family support to improve diabetes-related outcomes. We define community as the overarching ecosystem through which family and peer support is leveraged. Families and peers are defined broadly to include biological kin and individuals who comprise current and potential new social networks. These may consist of colleagues, neighbors, fellow church members, participants in a group medical visit, members of a virtual community, and even well-designed apps. Thus, this Core emphasizes a) the exchanges within and between communities, families, and peers (i.e., overlap); b) the characteristics and processes they share (i.e., interact); and c) the reciprocal association between their influence and their contexts – lifestyle, disease characteristics, stage of life, etc. (i.e., function). The Core supports studies into these topics, including interventions anchored in communities and health care systems that utilize community, peer, or family influences, broadly defined. To improve the design, implementation, and evaluation of interventions, this Core also supports studies exploring community, peer, and family support paths and how different contexts shape them. This Core’s objectives are centered on how support from communities, peers, and families impact and can best be mobilized to promote substantive positive changes in the lives and health of those affected by diabetes. The Core is an outgrowth of the Michigan-UNC Peer Support Core, funded through the Michigan Center for Diabetes Translational Research, 2016-24. It continues the Peer Support Core’s emphasis on the variety of peers and peer support approaches and the processes that undergird them, while expanding on these to include families and communities. With its national focus, the Core will serve colleagues at the University of Michigan, the University of North Carolina-Chapel Hill, and diabetes researchers across the US. This will include individual consultation to researchers and on research projects, national outreach, and facilitation such as through webinars and annual research workshops of a national Special Interest Group of researchers interested in the contributions of and interactions among community, peer, and family supports for improving diabetes prevention and management.